Non-enzymatic post-translational modifications as drivers of AD pathology

PROJECT SUMMARY
Alzheimer's disease (AD) is the most common form of dementia, and its association with type 2 diabetes is
well established. However, the molecular mechanisms underlying this link are not fully understood.
Hyperglycemia and dysregulated glucose metabolism have been suggested as factors contributing to the
increased risk of AD. This project aims to investigate the role of glycated tau and advanced glycation end
products (AGEs) in AD pathology, neurotoxicity, aggregation, and neuroinflammation. The proposed research
will pursue the following aims: Aim 1: Investigate how tau proteoforms with specific saccharide modifications
control aggregation and neurotoxicity. Aim 2: Expand in vitro studies to other reactive dicarbonyl species
operating through a mechanism similar to glycation. Aim 3: Evaluate the effects of glycation, AGE structure,
and attachment of DOPEGAL on interneuronal transmission, inflammation, and mitochondrial
dysfunction/oxidative stress. These studies will use hiPSC-derived models and will be accompanied by
extensive biophysical and biochemical characterizations to develop a molecular understanding of the role of
non-enzymatic post-translational modifications in AD. Successful completion of these aims will enable a more
precise diagnosis of AD and can potentially lead to novel therapeutic approaches based on the perturbation of
non-enzymatic modifications of tau and other proteins implicated in neurodegenerative diseases. Overall, this
research will provide important insights into the molecular mechanisms of AD and may lead to the
development of new treatments for this devastating disease.

Public health relevance
PROJECT NARRATIVE Alzheimer's disease and type 2 diabetes mellitus are two of the most prevalent diseases in the elderly population. This project aims to understand at the molecular level why diabetic patients are at a higher risk of developing dementia by studying the relationship between hyperglycemia and protein aggregation.